Emergency Responder Training Program

The International Association of Fire Fighters (IAFF) proposes to continue its nonacademic occupational safety and health training program to meet the specific training needs of fire fighters. The major objective of this program is to address the burden of occupational safety and health among fire fighters by providing state of the art training by translating scientific discoveries into practice through effective education, training, and outreach. Through this continued cooperative agreement, the IAFF will: 1) Enhance the capabilities of fire fighters engaged in emergency response through the delivery of existing professionally developed occupational safety and health training programs that are site-specific and trade- specific. 2) Maintain, update and/or create training curricula consistent with the threats posed to fire fighters and ensure curricula is reviewed and or accredited by appropriate third-party agencies as available. 3) Utilize innovative program evaluation protocols to demonstrate training effectiveness and ensure the training program meets and exceeds regulations and national standards resulting in fire fighters who are capable of performing in an effective, efficient, and safe manner.

Public health relevance
The International Association of Fire Fighters (IAFF) is proud to be a partner with the National Institute of Occupational Safety and Health (NIOSH) for nearly 20 years. The IAFF has continued its nonacademic occupational safety and health training program to meet the specific training needs of fire fighters. The major objective of this program is to address the burden of occupational safety and health among fire fighters by providing state of the art training by translating scientific discoveries into practice through effective education, training, and outreach. The IAFF recognizes that every emergency call is a potential hazardous materials (HazMat) call. Each year thousands of fire fighters are exposed to chemical and biological hazards in the performances of their duties. The IAFF understands that training students in hazards, defensive actions, and to OSHA and NFPA standards can help minimize and eliminate exposures. Our mission is to train all levels of firefighters in their own departments and customize the training to jurisdictional hazards. IAFF programs are developed and taught by highly trained fire fighters who bring valuable experience to the classroom. IAFF training efforts have proven to reduce risk and protect fire fighters safety and health through effective training.